Efficacy and safety of a new hexadentate iron chelator therapy for TBI-induced chronic disabilities in a rodent model

Traumatic brain injury (TBI) care and rehabilitation presents significant current and future challenges to the
Veterans Health System (VHS). In addition to specific disabilities, there is a growing concern that TBI may
significantly elevate risk factors for long-term chronic inflammation-induced progressive disease. Currently,
effective therapies to address both of these issues are hampered by the lack of a sufficient neurobiological
foundation to guide refinement of therapy for disability, and prevention strategies for chronic disease.
Acceleration/deceleration TBI causes micro-vessel shear injury, blood brain barrier (BBB) dysfunction, and
micro-bleeding. Iron deposited by diffuse micro-bleeds fuels inflammation through reactive oxygen species
(ROS), and other inflammatory pathways may further induce progressive disabilities. There is an urgent need to
address both specific disabilities and risk factors for long term progressive disease, and to develop effective
therapies that have excellent potential for translation. The proposed pre-clinical studies will increase our
understanding of microbleed (iron)-induced inflammation and the potential therapeutic benefits provided by a
new iron chelating drug to address three long-term hallmark TBI disabilities that significantly impact the quality
of life. The proposal will test the preclinical evaluation of the safety and efficacy of a new hexadentate iron
chelator, NaHBED, to remove microbleed-induced iron, a powerful catalyst of inflammation, and to upregulate
neural and vascular trophic agents to protect and heal injured neural and vascular tissues. Accordingly, three
specific aims are proposed: Specific Aim 1: To correlate TBI-induced chronic disorders with cellular/molecular
changes in LC and specific neural substrates of test behaviors in three functional domains. Tests for motor,
anxiety, cognitive functions, and a comprehensive safety protocol will be conducted immediately before and
monthly for 3 months post-treatment to evaluate the safety and efficacy of treatment. Clinically relevant state of
the art Susceptibility weighted imaging (SWI)/Quantitative Susceptibility Mapping (QSM) MRI, and histological
and immunohistological experiments will be performed to chart the time course for iron removal and/or further
iron deposition. Specific Aim 2: (Therapeutic efficacy). To determine the efficacy of NaHBED therapy in
mitigating long-term motor, cognitive and anxiety disabilities. Chronic treatment will be initiated at 6 months post-
TBI using a dose shown in preliminary work to be effective. In addition, to temporal characteristics and progress
of iron elimination and/or further iron deposition following NaHBED therapy (SWI/QSM MRI), the therapeutic
impact on chronic motor, anxiety, and cognitive disabilities will be assessed immediately before and monthly for
3 months following the initiation of treatment. Specific Aim 3: To determine the safety and efficacy of NaHBED
in reducing iron toxicity and up-regulating of trophic factors at the cellular level in the neural regions for motor,
cognitive, and anxiety behaviors, using comprehensive histological, immunohistochemical, and molecular
assays. We propose that treatment will significantly decrease the magnitude of long-term motor, cognitive and
anxiety disabilities and these improvements will be correlated with significant decreases in a) cell death, b) iron
deposition and neurodegenerative markers for inflammation and ROS, c) normalization of BBB markers, and d)
significant increases in neural and vascular protective factors in the specific neural centers that provide key
neural substrates for the studied behaviors. These chronic TBI studies address specifically highlighted RR&D
concerns regarding TBI-induced long-term disabilities, and long-term degenerative disease (RX-18-014). In
particular, these studies will provide new insights regarding TBI-induced factors that potentially contribute to
significant chronic inflammation-induced TBI disabilities. Since these risk factors are prevalent in both impact
acceleration (vehicular) TBI as well as blast TBI, they affect the predominant VHS TBI population. If our proposed
treatment is determined to be safe and effective in the chronic TBI setting, it is well positioned for immediate
translation to clinical treatment and rehabilitation since it obtained an IND approval for other disorder.

Public health relevance
Closed head traumatic brain injury (CH-TBI) has been a major component of injury in Iraq and Afghanistan with lingering quality of life eroding disabilities such as spasticity, gait, balance, anxiety and cognitive disorders that produce a substantial health care responsibility. There are also rapidly growing concerns that TBI is a risk factor for lingering inflammation that can significantly increase the risk of progressive neurodegenerative disorders in the future. Accordingly, there is an urgent need to increase our understanding of injury-induced long-term disability mechanisms, and to test the safety and efficacy of therapeutic measures that target these mechanisms utilizing approaches that have excellent potential for rapid translation. The proposed studies focus on TBI- induced microbleeds mediated neural, vascular, and inflammatory injury and their treatment. Translation of these findings may provide safe and effective intervention strategies that can significantly benefit the veterans’ health care system.